Integrative characterization of cell state via modeling of multi-omics data

PROJECT SUMMARY
Advent of singe-cell genomics has enhanced our ability to study heterogeneous cell populations (1) to track the
time course of cellular differentiation and identify drivers, (2) to identify potentially novel cell states/types in an
unsupervised manner, and (3) to identify cell populations that are linked disease outcomes. More recently, we
and others have developed single-cell multiomics technologies that enable measuring of multiple modalities of
a single cell at the same time, including the transcriptome, the methylome, the epigenome and surface marker
proteins. These assays offer unprecedented opportunities to study the state of single cells more
comprehensively; by developing the necessary computational methods for these assays, we can obtain more
accurate and deeper characterization of cell states and obtain mechanistic insights into the relationships
between state of chromatin, the proteome and the transcriptomic states within an individual cell. However,
there is a dramatic lack of interpretable computational methods to study multiomics data. To address this gap
and propel the field forward, we are proposing to develop computational methodologies that will (1)
characterize the state of a single cell in a multiomic setting in an unsupervised manner, (2) characterize the
regulatory landscape of single-cells by identifying transcription factor binding activity and (3) identify multiple
structural variations at single-cells.
First, we will develop interpretable topic-modeling based methods for characterizing single cells based on
multiomic readout. Building on our past success with topic models to accurately cluster and characterize
single-cell populations, we will develop novel topic modeling approaches for multiomics assays in order to
achieve a much deeper profiling of the state of a cell, which will lead to potential insights into the links between
multiple modalities measured by a multiomic assay, such as transcriptomic and epigenomic state. Second, we
propose to develop a single-cell transcription factor footprinting (TF) methods. Computational detection of TF
footprints can identify the landscape of active transcription factors that determine important drivers of cell state
and identity. We will develop the methodology to identify active transcription factors at an unprecedented
single-cell resolution and to investigate links between the methylome and TF binding. Lastly, we will develop
methods to identify different types of structural variations at single cell resolution by leveraging novel multiomic
assays developed by my collaborators. This methodology will enhance our ability to study the heterogeneity of
structural variations in different cell populations. Overall, the proposed suite of computational methodologies
will allow a broad audience of researchers who generate and analyze multiomic data to annotate the multi-
modally measured cell states in heterogeneous cell populations in a deep and unprecedented manner at
single-cell resolution. Furthermore, our interpretable methods will yield testable hypotheses to better
understand the cell state.

Public health relevance
PROJECT NARRATIVE In the past decade, dramatic advancements in high throughput singe-cell genomics and multiomics have enhanced our ability to study heterogeneous cell populations, making it possible to study cell states that make up complex tissues and organs, and to better understand cellular transitions that happen during temporal processes such as differentiation and disease development. Most recently, we have gained the ability to concurrently measure multiple modalities from the same single cell - including the transcriptome, the methylome, the epigenome, and the proteome -; however, interpretable computational models to characterize and annotate cells subjected to multiomic measurement are lacking. Here, we propose to develop interpretable machine learning models to enable integrated analysis of multiomic single-cell data to enable deep and comprehensive characterization of heterogeneous cell populations at multiple scales.